Chronic Renal Insufficiency Cohort Limited competition continuation

PROJECT SUMMARY
Case Western Reserve University (CWRU) proposes to continue to serve as a clinical center for Phase 5 of
the Chronic Renal Insufficiency Cohort (CRIC) Study. Chronic kidney disease (CKD) affects over 37 million
Americans who are at risk of progression to end stage kidney disease and development of cardiovascular
disease and other comorbidities associated with disability, high costs of care and premature mortality. Since its
inception in 2001, the CRIC Study has recruited and followed a racially and ethnically diverse cohort of 5,625
participants with reduced kidney function from 13 recruitment sites at 7 Clinical Centers across the US. The
original aim of CRIC was to establish a clinical research laboratory designed to (a) identify novel predictors of
CKD progression, and (b) characterize the manifestations of cardiovascular disease and identify its risk factors
among individuals with CKD. As the landmark prospective cohort study of CKD, the CRIC Study has
accomplished extensive biological, physiological, and social phenotyping, longitudinal follow-up, and
ascertainment of clinical and patient-centered outcomes across multiple domains. Findings from the CRIC
Study have defined trajectories of CKD progression, catalogued development and evolution of comorbidities in
CKD, and identified a diverse array of factors and pathways that explain the progression and complications of
CKD in adults. Through its highly productive Ancillary Studies and Opportunity Pool Programs, both the
scientific scope of the CRIC Study and the community of kidney disease researchers have been markedly
expanded. During the most recent funding cycle (Phase 4: 2018-2023), three innovative sub-protocol studies
were implemented to enrich CRIC data with highly granular home-based assessments of kidney function and
cardiovascular measures. During the fifth and final phase of the CRIC Study, the major focus will be to (1)
ascertain the clinical outcomes for all participants including those enrolled in the Phase 4 sub-protocols, (2)
perform analyses linking the sub-protocol measurements to clinical outcomes, (3) integrate data from multiple
domains to identify sub-phenotypes underlying the heterogeneity in CKD progression outcomes, (4) conduct
final study visits for the full CRIC cohort eligible for Phase 5, (5) create mechanisms for future data collection
via linkages with external sources of health data, and (6) generate tools and resources to facilitate ongoing use
of CRIC data and biospecimens by a broad group of investigators after the CRIC Study has officially ended.
CWRU investigators will work closely with the Scientific and Data Coordinating Center and other CRIC
investigators to generate new scientific output and successfully transition the CRIC Study from its active
prospective cohort phase to a long-lasting resource for supporting ongoing and future mechanistic,
epidemiologic, and translational investigations.

Public health relevance
Project Narrative The CRIC study is designed to study the reasons why kidney disease progresses over time, and to identify factors that contribute to development of heart disease. Over the last 20 years, this study has established an impressive infrastructure; we now propose to extend this study for another 3-year period to obtain additional information about kidney and heart conditions. This will help advance our understanding of kidney disease, and how it influences heart disease.